CHANGES IN IGF-1 CONCENTRATIONS ON PULSATILE GH SECRETION

The purpose of this study is to compare pulsatile GH secretion in fasted subjects during euglycemic hyperIGF-1-emic clamp experiments and saline infusions.